HEALing Communities Study Data Coordinating Center

PROJECT SUMMARY/ABSTRACT
A seeming unrelenting opioid crisis is devastating the United States, with rural states and communities being
hit especially hard. Actionable guidance is desperately needed to curb the death and devastation caused by
opioid misuse and addiction. Recognizing the urgent need, the National Institute on Drug Abuse (NIDA) and
the Substance Abuse and Mental Health Services Administration (SAMHSA) plan to launch the HEALing
Communities Study (HEAL) to reduce opioid overdose fatalities by at least 40% in 3 years. Three research
sites (RSs) and a data coordinating center (DCC) will be created to evaluate the implementation of evidence-
based prevention and treatment interventions, and their cost and cost-effectiveness. RTI proposes to serve
as the DCC for HEAL. In this capacity we will provide coordination and facilitate communications to unite the
HEAL members into a cohesive research cooperative (Aim 1a). We will work with the RSs to apply
implementation science methods to understand the barriers and facilitators to successful uptake of proven
interventions in health care, behavioral care, criminal justice, and other public health settings (Aim 1b). Novel
insights will be gained through the application of advanced data management, biostatistics, analytic, and
computing techniques (Aim 2). We have the infrastructure in place to support rapid study start-up and
efficient operations. Data harmonization will be enhanced using innovative methods and tools for selecting
common data elements and for transforming data from many administrative systems to a consolidated HEAL
data model. We will conduct health economics research to determine the incremental costs of start-up and
ongoing implementation, and the cost-effectiveness of evidence-based approaches to mitigate the opioid
epidemic (Aim 3). We will develop a microsimulation model that will inform optimal resource allocation to
achieve target reductions in opioid overdose deaths and other negative outcomes. We will develop the
Opioid Policy Simulator as a translational tool for communities (internal and external to HEAL) to use as they
plan their own interventions to reduce opioid effects in their locales. The Simulator will be an interactive
online tool to help decisionmakers synthesize information from multiple sources and select the combination
of interventions best suited for their community. Our DCC team, led by multiple Principal Investigators Drs.
Rick Williams, Gary Zarkin, and Kevin Conway are experienced leaders of multi-site studies and experts in
data harmonization, biostatistics, health economics, and addiction etiology. Our broader team of
investigators and consultants brings robust scientific and implementation science skills interwoven with a
deep understanding of the opioid crisis.

Public health relevance
PROJECT NARRATIVE A grim opioid crisis is devastating the United States, with rural states and communities being hit especially hard. Provisional data from 2017 show there were 49,068 opioid-related deaths in the U.S.—about a 5-fold increase since 2000. As the Data Coordinating Center, RTI will coordinate the HEALing Communities Study, pooling data from Research Sites around the country that are testing ways to prevent and treat deadly opioid use, to ultimately provide desperately needed actionable guidance to curb the death and devastation.